StARR Program in Cross-Disciplinary Oncology Clinician-Scientist Training

PROJECT SUMMARY/ABSTRACT
The over-arching goal of the Washington University (WU) StARR Program in Cross-Disciplinary Oncology
Clinician Scientist Training is to IDENTIFY, RECRUIT, TRAIN, RETAIN, and ADVANCE outstanding physicians
in oncology-focused graduate medical education (GME) training (i.e. “residency”) for careers as clinician-
investigators. We have proposed training clinician resident-investigators from diverse, oncology-focused
disciplines and residency training programs.
Long-term objectives: The WU NCI R38 StARR program will successfully identify, recruit, and train oncology-
focused clinicians with an interest in becoming clinician-scientists during their residency training. These trainees
would then be eligible for subsequent career-development awards, including the companion K38 mechanism.
Our program plan includes continued long-term follow-up and engagement of R38 trainees to retain and advance
their careers as physician-scientists.
Key Elements of Training: An emphasis of our proposal includes multiple levels of career development, including
co-mentoring by at least two mentors in different departments to encourage cross-disciplinary training and
collaboration. Each resident-investigator will also have a mentoring committee and report regularly to the PI and
Advisory Committee. A structured curriculum with specific competencies and milestones will be established to
best train individual resident-investigators in programs and research programs that are ideally matched with their
skills, interests, and career development. We have received broad support from all levels of research and
education at WU, including the Dean’s Office and the participating Departments and Programs.
Research Projects: The WU NCI R38 StARR program will support up to four resident-investigators per year
from the participating departments. Each resident-investigator will engage in 1-2 years of dedicated, protected
research time, free from all clinical responsibilities. They will craft a research plan commensurate with their
interests and prior experiences that may involve further training, coursework, workshops, and career
development. Specific metrics and plans for follow-up, evaluation, and long-term mentoring and career
development are included in our proposal.
The WU StARR Program in Cross-Disciplinary Oncology Clinician Scientist Training will leverage the significant
institutional, departmental, and programmatic resources at our University to meet the stated goal of the StARR
program to recruit and retain outstanding health professionals to foster their careers as clinician-investigators.

Public health relevance
NARRATIVE Continued progress in oncology relies on training the next generation of physicians for careers in research. The Washington University StAAR Program in Cross-Disciplinary Oncology Training will IDENTIFY, RECRUIT, TRAIN, RETAIN, and ADVANCE outstanding physicians in oncology-focused graduate medical education (GME) training (i.e. “residency”) for careers as clinician-investigators.